Research Training in Otolaryngology

DESCRIPTION (provided by applicant): The purpose of the proposed competing renewal for Research Training in Otolaryngology is to provide a two-year period of uninterrupted research training for one individual per year during the course of clinical residency training in otolaryngology-head and neck surgery. As in the past, the clinical training program at Harvard/Massachusetts Eye and Ear Infirmary has two separate tracks, a clinical track and a research track, and it is in that latter research track that training will be supported. The educational objective of the training program is to prepare the selected trainees for an academic career in otolaryngology-head and neck surgery and to prepare them to successfully compete for peer-reviewed funding for research. The program provides opportunity for research training in established laboratories under the mentorship of individuals with a track record of peer-reviewed research support in a wide variety of research laboratories in the Department of Otolaryngology at the Massachusetts Eye and Ear Infirmary, its affiliated hospitals, including Children's Hospital of Boston, The Massachusetts General Hospital, Brigham and Women's Hospital, Harvard Medical School, and the Massachusetts Institute of Technology. The research opportunities include a wide variety of basic, clinical and translational research in hearing, balance, laryngology and voice, molecular biology and genetics, head and neck neoplasia, laser technology, and neuroprostheses. The applicants will be drawn from a pool of approximately 230 applicants on a yearly basis for residency training in otolaryngology, which includes specific recruitment of individuals from underrepresented racial/ethnic groups. The educational program includes training in responsible conduct of research and specific mentorship in the application process for peer-reviewed funding. The application pool will be interviewed by a residency selection committee which includes representation from members of the research community.

Public health relevance
PUBLIC HEALTH RELEVANCE: The true benefit of biomedical research to public health depends upon swift and efficient translation of scientific discoveries into the healthcare domain. This translation is accomplished first and foremost by the cadre of "bilingual" clinician-scientist who are at home in both the world of science and the world of clinical medicine. Our program aims precisely to nurture the development of such clinician-scientists in the field of otolaryngology - head and neck surgery.